Investigation of Glycosylphosphatidylinositol (GPI) Anchorage and GPI-Anchored Proteins

Program Director/Principal Investigator (Last, First, Middle): GUO, Zhongwu
Investigation of Glycosylphosphatidylinositol (GPI) Anchorage and GPI-Anchored Proteins
Glycosylphosphatidylinositol (GPI) linkage to the protein C-terminus is one of the most common and important
post-translational modifications. GPI-linked proteins are anchored onto the outer leaflet of the cell membrane to
play a critical role in various physiological and pathological processes, such as cellular recognition, adhesion and
signaling. However, in-depth investigations of GPI anchors and GPI-anchored proteins (GPI-APs) are challenging,
largely because of their complex and diverse structures and amphipathic property as well as the lack of appropriate
research tools and methods to study GPIs and GPI-APs.
The goal of this project is to overcome the challenges by developing new probes, including efficient methods for
the synthesis of these probes, and research methods to facilitate GPI/GPI-AP investigation and fill out an important
scientific gap. Specifically, the future research directions of this project will include: 1) developing new molecular
tools, including both DNA/RNA aptamers and fluorescent DNA probes, and methods for sensitive GPI detection to
facilitate studies of GPI-APs on live cells; 2) developing new probes and methods for GPI-AP labeling and isolation
to enable their characterization and high throughput analysis, and examining GPI-anchored proteomics expressed
by different cells to discover new molecular markers; 3) developing new probes and methods to enable the study
of the membrane organization and other biophysical properties of GPIs/GPI-APs, and exploring the mechanisms
by which GPI-APs act as mechanotransducers in various binding and signaling events; 4) developing new probes
and research methods to enable studies of GPI-cell membrane interaction, and identifying GPI-binding proteins
in the cell membrane involved in GPI-mediated signaling and other processes like GPI-AP trafficking.
This project is innovative and will have a big and broad impact, since it addresses several important, unresolved
challenges associated with GPI-AP research and helps comprehend the biological significances of GPI anchorage
at large. Particularly, through systematic and in-depth investigations, it will allow access to a diversity of probes
and research methods for biological studies of GPIs/GPI-APs and provide useful information about the organization
of GPIs/GPI-APs on the cell surface, GPI binding with other biomolecules in the cell membrane, and GPI-anchored
proteomics. The results will not only help better understand the functional roles and mechanisms of GPIs and GPI-
APs in various biological processes but also help uncover novel GPI-APs and GPI-interacting proteins related to
cellular recognition and signal transduction and novel biomarkers useful for development of innovative diagnostic
and therapeutic strategies for human diseases.
OMB No. 0925-0001/0002 (Rev. 10/2021 Approved Through 01/31/2026) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): GUO, Zhongwu Many surface proteins are anchored onto the outer leaflet of the cell membrane by a group of glycolipids called glycosylphosphatidylinositol (GPI). GPI-anchored proteins play an essential role in many important biological and pathological processes. However, in-depth investigation of these processes is hindered by the lack of tools and approaches to study GPIs and GPI-anchored proteins. This project aims to address the problem by establishing new molecular probes and research methods to enable sensitive detection and analysis of GPIs and GPI-anchored proteins on live cells, biophysical studies of GPIs within the cell membrane, and GPI binding and interaction with other membrane components. The research results are useful for a better understanding of the functional roles and mechanisms of GPIs in many biological processes and discovery of new biomarkers for the development of innovative diagnostic and therapeutic strategies for human diseases. OMB No. 0925-0001/0002 (Rev. 10/2021 Approved Through 01/31/2026) Page Continuation Format Page